Postdoctoral Training in Health Services Research

PROJECT SUMMARY/ABSTRACT
This application seeks renewal of support for the University of Pennsylvania’s (Penn’s)
postdoctoral training program in health services research (HSR). The program’s overall goal is
to train investigators to conduct independent, rigorous, and high-impact HSR and thereby
improve the quality, safety, efficiency, and equity of health care organization, financing, and
delivery. Our program leverages Penn’s well-established institutions and resources dedicated to
producing high-quality and high-impact HSR, including top-tier educational programs,
outstanding faculty and mentorship, a robust research infrastructure, and a strong institutional
commitment to HSR. Addressing the complex challenges facing the nation’s healthcare system
requires diverse perspectives and partnerships across multiple academic disciplines. In
recognition of this, we have designed our post-doctoral training program for both clinicians
seeking to become clinician-researchers by acquiring HSR skills, as well as PhD-trained
economists seeking to apply their methodological expertise to the field of HSR. Our program not
only develops these competencies for both trainee groups, but also, by linking clinician-
researchers with PhD-trained postdocs in Penn’s collaborative and interdisciplinary HSR
training environment, we aim to develop leaders who can build diverse and inclusive
investigator teams that combine disciplinary and institutional expertise. Our T32 program will
continue to be administered by Penn’s Perelman School of Medicine, which houses one of our
training program’s key educational curricula—the Master of Science in Health Policy
Research—and will closely collaborate with Penn’s Leonard Davis Institute for Health
Economics (LDI), which runs the second key training program component—LDI’s postdoctoral
program for health economists. The Perelman School and LDI have a long and robust history of
successful collaborations. This program will also continue to draw on additional faculty expertise
and mentoring from Penn’s Wharton School, Penn’s School of Nursing, and the Children’s
Hospital of Philadelphia. Together these entities are well suited to provide the highest quality
training environment to both clinician-researchers and PhD-trained economists seeking to
become independent and influential health services researchers. Thus, our HSR training
program capitalizes on Penn’s unique strengths and long history in fostering cutting-edge
research across its schools and disciplines. Our program’s graduates will have the necessary
skills to address the health care delivery system’s most pressing problems and make health
care organization and delivery higher quality, safer, more efficient, and equitable.

Public health relevance
PROJECT NARRATIVE Addressing the complex challenges facing the nation’s health care system requires diverse perspectives and disciplines. This post-doctoral training program is designed for both clinicians seeking to become clinician-researchers by acquiring health services research skills, as well as PhD-trained economists seeking to apply their methodological expertise to the field of health services research. We aim to train future leaders in health services research who will address our health care delivery system’s most pressing problems and make health care organization and delivery higher quality, safer, more efficient, and equitable.